Investigating the role of myosin-based force generation in protrusion formation.

PROJECT SUMMARY/ABSTRACT
In Eukarya, actin-based protrusions such as filopodia, stereocilia, and microvilli, support a wide variety
of cellular functions including motility, mechanosensation, and nutrient absorption. Formation of a surface
protrusion involves deformation of the plasma membrane, and previous studies indicate that actin polymerization
produces the mechanical force to displace the membrane forward. In addition to the force generated by actin
polymerization, protrusion formation may also be powered by other factors. Indeed, the actin-based force
generators, myosins, are some of the most abundant residents of actin-based protrusions. Previous research
has shown that these motors function as cargo carriers to move critical components needed for assembly to the
distal tips. However, only some of the myosins in protrusions are known to carry cargo, while all interact either
directly or indirectly with the plasma membrane. As all myosin motors found in actin-based protrusions are also
able to exert force, we hypothesize that myosins likely hold the potential to apply a significant impact on the
mechanical properties of the membrane. Indeed, based on our preliminary data we have discovered a
secondary, cargo-independent pathway for promoting protrusion growth by docking the force generating myosin-
10 motor on the plasma membrane. We hypothesize that myosins exert tipward forces on the plasma
membrane to promote actin assembly and protrusion elongation. To test this hypothesize, we will determine
how myosin motors drive protrusion elongation by manipulating the mechanical properties of myosin-10, as well
as docking additional classes of motor domains on the plasma membrane. Next we will define which modes of
membrane attachment impact protrusions elongation by docking the myosin-10 motor domain to three different
membrane attachment constructs (i.e. a transmembrane domain, a phosphatidylinositol, or to the negative
charge of the inner leaflet of the membrane). Lastly, we will determine how membrane-interacting myosins
impact the growing, barbed-ends of filamentous actin (F-actin) assembly by using transmission electron
microscopy to visualize the cytoplasmic compartment of the distal tips of protrusions formed in our system. If
successful, this research will expand the dogma that myosins assist in protrusion elongation by acting as cargo
carriers. This project seeks to understand how membrane-bound myosins drive actin-based protrusions
formation in diverse biological settings, which has broad implications for understanding diseases such as Crohn’s
disease, deafness, and cancer.

Public health relevance
PROJECT NARRATIVE Actin-based protrusions are evolutionarily conserved structures that contribute to a range of specialized cell functions including nutrient absorption, hearing, and sensing external cues. Utilizing state-of-the-art live cell imaging and biochemical approaches, we have discovered a new mechanism for forming protrusions by docking the force-generating motor, myosin, to the plasma membrane. This project seeks to understand how this mechanism drives actin-based protrusion formation in diverse biological settings, which has broad implications for understanding diseases such as Crohn’s disease, deafness, and cancer.